2025 Cerebellum Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
This proposal seeks partial funding for the 2025 Gordon Research Conference (GRC) and Gordon Research
Seminar (GRS) on Cerebellum. The events will be held at Les Diablerets, Switzerland, a location chosen for both
its seclusion for scientific exchange, its accessibility within a 4-hour flight from most of Europe, North Africa, and
the Middle East, and easy access from the USA and Asia. The GRS, exclusively for trainees and managed by
students and postdoctoral fellows, is scheduled for 7/5/25-7/6/25. The subsequent 5-day GRC, accommodating
up to 200 participants, will run from 7/6/25-7/11/25. Recognized as the preeminent forum for cerebellar research,
this conference unites a diverse international group of established investigators and trainees. The past five years
have seen a substantial expansion of our understanding of the cerebellum's role beyond motor control to include
cognitive functions. The 2025 GRC Cerebellum seeks to synthesize this remarkable progress with the firm and
longstanding foundation established by the cerebellum as a motor-oriented brain structure. This dual role for the
cerebellum provides the potential to provide conceptual linkages between movement disorders like ataxia,
dystonia, and tremor to neuropsychiatric conditions such as autism spectrum disorder, ADHD, and
schizophrenia. Our goal is to construct a novel, integrated framework for understanding cerebellar function by
harnessing unique concepts and technologies from various disciplines to address challenging questions. The
2025 Cerebellum GRC will bring together advanced methodologies from molecular biology, physiology, anatomy,
computation, and behavior. We have curated a diverse panel of 33 speakers (45% female, 24% early-stage
investigator, 9% under-represented minorities). Each session is designed to tackle an unresolved problem,
featuring a combination of speakers with expertise in neuroanatomy, developmental genetics, neurophysiology,
disease mechanisms, and therapeutics. This integrated approach aims to stimulate lively and collegial
participation from attendees at all career stages and across all disciplines. Both the GRS and GRC will feature
talks by world-renowned keynote speakers. Poster sessions will provide a platform for attendees to present
unpublished work. Additionally, we will host a "Power Hour" to promote diversity in cerebellar science and an
informal session on grantsmanship and successful grant writing strategies. We are committed to fostering the
future of women and underrepresented minorities in cerebellar research. The overarching theme of GRC
Cerebellum 2025 is to leverage the field's breadth and depth to nurture the next generation of scientists. Through
this conference, we aim to advance our understanding of the cerebellum's complex roles across many domains
and its potential as a therapeutic target for many neurological and psychiatric conditions.

Public health relevance
PROJECT NARRATIVE The 2025 Gordon Research Conference and Gordon Research Seminar on Cerebellum will bring together scientists and clinicians who study the cerebellum, a brain region found in all vertebrates that controls a variety of functions including motor, sensory and cognitive processing. The centrality of the cerebellum to diverse brain functions is consistent with its involvement in a wide range of brain disorders such as ataxia, dystonia and tremor, but also in a growing list of non-motor conditions including autism spectrum disorders, attention deficit hyperactivity disorder and schizophrenia. This GRC will bridge gaps between these functional domains, spur organic interactions to cultivate multidisciplinary, international research collaborations, and identify novel cerebellar therapeutic targets.